The Malate-Aspartate shuttle links dietary fatty acids to inflammatory responses in dendritic cells

Abstract
Obesity and Western diet are known risk factors for incident psoriasis, and they aggravate existing
psoriasis. The development of psoriasis depends on the cytokine IL-23 produced in the skin and lymph
nodes by dendritic cells (DCs) and macrophages. There is mounting evidence that diets rich in fatty
acids exacerbate psoriasis by enhancing inflammatory pathways in the skin, including increased IL-23
production. However, molecular mechanisms that link dietary fatty acids to IL-23 production are not
completely understood.
We have recently shown that, in a mouse model of psoriasis, IL-23-producing DCs mediate the harmful
effect of a diet rich in fat to skin inflammation. This was due to the metabolic reprogramming of DCs by
dietary palmitic acid (PA), which resulted in enhanced unfolded protein response (UPR) in the
endoplasmic reticulum and increased IL-23 expression. We have demonstrated that the deficiency of
the UPR-activated transcription factor XBP1 in DCs diminishes IL-23 expression and protects mice
from the HFD feeding-mediated exacerbation of psoriasis. Thus, it is critical to identify the molecular
link between the metabolic reprogramming of DCs and the UPR-dependent inflammation to dissect
interplay between obesity and exacerbated psoriasis. Our preliminary results indicate that PA induces
mitochondrial stress and enhances the UPR and IL-23 expression via the activation of the Malate-
Aspartate shuttle (MAS), a central metabolic pathway connecting glycolysis with respiratory activity of
mitochondria. Accordingly, the major premise of this project is that understanding how the Malate-
Aspartate shuttle connects a high fatty acid environment to a specific inflammatory response
will open new avenues for therapeutic approaches to treat inflammatory diseases in obesity. In
this project, we will identify and validate metabolic, signaling, and immune components that regulate
IL-23 production in DCs in obesity. Specific Aim 1 is focused on understanding how PA reprograms
metabolism of DCs and mitochondrial function to increase Malate-Aspartate shuttle activity. Specific
Aim 2 is focused on characterization of molecular mechanisms that link the Malate-Aspartate shuttle to
the UPR and inflammatory function of DCs, with increased IL-23 expression as a hallmark, in psoriasis.

Public health relevance
Project Narrative This project is based on our recent work where we discovered that IL-23-producing dendritic cells connect the metabolic environment in obesity to exacerbated skin inflammation in psoriasis. This was due to the metabolic adaptation of activated dendritic cells to excessive dietary fatty acids, which enhances the unfolded protein response to increase IL-23 production. We found that a key metabolic pathway, the Malate-Aspartate shuttle, links the metabolic environment to the unfolded protein response and IL-23 expression, and propose to identify molecular mechanisms of this process to understand how obesity aggravates skin inflammation in psoriasis.